Identifying cross-situational word learning mechanisms across development

Project Summary/Abstract
Vocabulary acquisition is a crucial component of children’s early development, laying the groundwork
for early success in school and enabling children to communicate with and learn from others. While children
rely on many word learning strategies to build their vocabularies, recent research has revealed a powerful role
for cross-situational word learning. Even when a word’s meaning is ambiguous in one context (e.g., a child
hears “It’s a dog!” and several animals are present), children can use a series of these ambiguous utterances to
learn the word. However, the mechanism by which children do so is not clear: the Cumulative Statistics theory
proposes children track word-meaning co-occurrences across contexts while the Hypothesis Testing theory
proposes children collect evidence for or against only one hypothesized meaning, or previous hypotheses.
The proposed studies use behavioral, eye-tracking, and computational modeling methods to evaluate
these rival word learning mechanisms. The studies take a developmental approach, asking how children’s word
learning abilities change from 2 to 7 years of age and into adulthood, as well as what learning mechanisms best
account for these changes. This work will also provide the first evidence regarding whether children can learn
verbs across semantically ambiguous contexts: novel verbs can refer to separate aspects of a single event (such
as the manner or path of motion), presenting a challenge for children’s learning. Finally, we examine a related
prediction from the memory literature: that word learning will be improved when learners encode a word’s
potential meanings in an integrated event representation. These studies address fundamental questions about
cross-situational learning’s mechanisms, scope, and underlying representations throughout development.
These findings will offer insight into how children learn words during an important period of language
development, stretching from preschool to 2nd grade, as well as how these abilities mature in adulthood. By
examining both nouns and verbs, these studies also provide a crucial test of how word learning strategies
previously documented for nouns extend to children’s acquisition of verbs, which pose additional challenges
and, as such, are later-acquired and can be especially hard for children experiencing language delays to learn.
In addition, these studies will reveal how the structure of word learning contexts, which often involve potential
word meanings being involved in a shared event, can enhance both noun and verb learning.
Finally, these studies will provide the applicant with critical postdoctoral training to advance his
career. The applicant will master the new methodological and theoretical skills necessary to examine
language learning throughout the lifespan and construct computational models of major language
learning theories. This training will be highly interdisciplinary, utilizing mentors, coursework, and
professional development activities across multiple departments and research organizations. This
training will ultimately prepare the applicant to become a successful independent researcher.

Public health relevance
Project Narrative The proposed research will investigate mechanisms of word learning throughout development, from 2 to 7 years of age and in adults. These findings will enhance our understanding of children’s powerful ability to learn words in ambiguous contexts and will yield new insights into the most effective learning strategies available to children when acquiring new words, including how these strategies vary across nouns and verbs. This work has substantial implications for our understanding of typical and atypical language development and for the design of effective linguistic interventions for children experiencing language delays.